Age-related neuronal regulation of thermogenesis and lipid metabolism

Project Summary
Aging is associated with obesity, cardiovascular disease, and type 2 diabetes mellitus. Activating brown adipose
tissue (BAT) thermogenesis in humans results in elevation of triglyceride clearance and insulin action, and has
great potential to combat obesity, cardiovascular disease, and type 2 diabetes mellitus. We have reported in
young adult mice that ACUTE injection of apolipoprotein A-IV(ApoA-IV): 1) elevates thermogenesis and uptake
of fatty acid (FA) in BAT and 2) stimulates sympathetic neural activity (SNA) in BAT but reduces SNA in liver of
chow-fed mice. However, its effect on lipid metabolism in adipose tissue and liver through alteration of SNA in old
mice remains unknown. Chronic consumption of high-fat diet (HFD) suppresses ApoA-IV production normally
induced by acute consumption of dietary lipids and attenuates SNA of BAT and thermogenesis. In this regard,
we have preliminary evidence in young, HFD-fed mice that CHRONIC infusion of ApoA-IV: 1) elevates
thermogenesis in BAT and beige adipose tissue (BeAT) and overall energy expenditure; 2) increases hepatic
expression of carcinoembryonic antigen-related cell adhesion molecule 1 (CEACAM1), implying restriction of
hepatic lipogenesis; and 3) reduces hepatic and plasma lipid content, fat mass, and body weight gain. These
findings suggest that chronic infusion of ApoA-IV alters lipid metabolism in BAT, BeAT and liver through neural
or CEACAM1-mediated pathways. Because elderly humans and older rodents have a large decline in BAT
activity, we theorize that the lower thermogenesis results in impaired lipid oxidation for energy combustion in
BAT/BeAT, insufficient FA uptake into these adipose tissues, and elevated lipogenesis and lipid accumulation in
the liver. Thus, we propose the innovative hypothesis that increased levels of ApoA-IV will act through
sympathetic innervation to elevate lipid oxidation and uptake in BAT/BeAT and through CEACAM1-mediated
reduction of lipogenesis in liver, subsequently reducing hepatic and plasma triglyceride (TG) in old, obese
animals. This hypothesis will be tested using comprehensive, innovative, well-designed approaches. Aim 1 will
investigate ApoA-IV’s role in sympathetic activation of BAT/BeAT to reverse age-attenuated thermogenesis. Aim
2 will investigate ApoA-IV’s effects on BAT/BeAT and hepatic lipid metabolism through neural or CEACAM1-
mediated pathways to lower hepatic and plasma triglycerides. A major strength of this proposal is the
interdisciplinary collaboration between Drs. Chunmin Lo (lipid metabolism & neurophysiology) and Haifei Shi
(neuroendocrine & adipose biology) with support from Drs. Sonia Najjar (aging & CEACAM1-meidated insulin
action), Darlene Berryman (aging & hormones) and Karen Coschigano (molecular biology & signaling
pathways). As demonstrated by the strong preliminary data, these investigators have productively collaborated
and will delineate the novel mechanism of ApoA-IV in downregulation of age-related obesity and plasma
triglycerides, leading to treatments against this health problem in elderly humans.

Public health relevance
Project Narrative Aging is associated with obesity, cardiovascular disease, and type 2 diabetes mellitus. Apolipoprotein A-IV (ApoA-IV) elevates sympathetic neural activity, thermogenesis, and overall energy expenditure in young mice. The proposed studies will identify the mechanisms underlying potential therapeutic applications of ApoA-IV in elevating thermogenesis and lowering obesity and plasma triglycerides through neural regulation of lipid metabolism in adipose tissues and the liver of old and young mice.